Adaptation and Pilot Test of a Universal School-Based Suicide Prevention Program

The Centers for Disease Control and Prevention reported that the suicide rate for females aged 10 –14 has
had the largest percent increase (200%) of any other demographic group between 1999 and 2014, tripling from
0.5 per 100,000 in 1999 to 1.5 in 2014. Although the rates of suicide are relatively rare in these ages, as
compared to older ages, the sharp increase in suicide among young people is alarming. Data from the 2016
Youth Risk Behavior Surveillance System showed that 27% of Baltimore City middle school students (ages 11-
14) reported having ever thought about killing themselves and 14% had ever attempted suicide. With suicide
being the second leading cause of death for persons ages 10-14, it is important to target prevention efforts
early. Almost all of the existing suicide prevention programs target suicide risk in high school, which is too late
to meet the needs of middle school students. The primary aim of this R34 pilot effectiveness trial is to establish
the feasibility, acceptability, preliminary impact, and potential for future uptake of the Youth Aware of Mental
Health (YAM) program. YAM is an evidence-based mental health promotion program administered in schools
that has been shown to be effective among primarily white European high school students ages 14 to 16 years
old. In a large randomized trial involving 11,110 students from 168 schools in ten European Union countries,
students randomized to YAM reported 55% lower incidence of suicide attempts and 50% lower incidence of
severe suicidal ideation over one year. YAM was chosen for the proposed study not just because of these
outcome data, but because it aligns with U.S. National Health Education Standards, and because it was
created with the heterogeneity of youth in mind. Our adaptation and implementation of YAM will include five
sessions delivered in middle school health education class by trained health education teachers. Given its
flexibility, YAM was designed with an eye toward community implementation, sustainment and scalability.
YAM’s proposed target mechanisms of action involve enhancing problem-solving and coping skills to manage
acute stressors. This pilot study will examine feasibility and acceptability of the proposed recruitment methods,
research design, intervention, assessment methods and training program in a school system with a majority
African American population by matching 7th and 8th grade classrooms by school and randomizing classrooms
to YAM or to the wait-list control condition. The primary outcomes will be suicidal ideation and mood symptoms
in the 3 months after YAM implementation. This proposed pilot effectiveness trial will lay the groundwork for a
larger clinical trial (R01) to evaluate the effectiveness of YAM on suicidal behaviors in urban middle school
students.

Public health relevance
Project Narrative Suicide is the second leading cause of death for children ages 10-14 in the United States and recent epidemiological trends indicate that suicidal ideation and attempts among children and adolescents are on the rise. Most school-based prevention programs have been developed and evaluated in high-school age populations. This grant will adapt an existing universal school- based suicide prevention program for an urban middle-school age population and evaluate its feasibility, acceptability and appropriateness as well as impact in two Baltimore City public middle schools.